Biomolecular Mass Spectrometry Facility CORE

This is the mission of the Biomolecular Mass Spectrometry Facility Core: ¿ provide exceptional support for environmental health-related research projects using state-of-the-art mass spectral analysis capabilities, ¿ develop new technologies with the ultimate goal of applying these new technologies to client projects, and ¿ serve as an educational platform for environmental health science research. The Biomolecular Mass Spectrometry Facility Core (BMSFC) gained its expertise in developing new instruments and ionization technologies over 30 years of measuring pesticides and toxicants in environmental samples. Persistent bioaccumulative toxicants are notoriously difficult to ionize and fragment by mass spectrometry. This challenge has driven much of our development efforts.